At the site of the bite: Immune Response to tick-transmitted Rickettsiae

PROJECT SUMMARY/ABSTRACT
Advancements in understanding the human immune response to spotted fever rickettsiosis (SFR) require a
translational animal model demonstrating clinical rickettsiosis after tick transmission of the spotted fever group
Rickettsia spp. (SFGR) agents of SFR. The guinea pig is an ideal model for studying SFR because it recapit-
ulates the disease after tick transmission, has an immune system demonstrably closer to that of a human than
a mouse, and allows for antemortem sample collection for multiple assays at sequential time points in longitu-
dinal studies. The latter characteristic makes the guinea pig uniquely informative because such sample collec-
tions from murine models would not be feasible. Here, we utilize the guinea pig-tick-SFGR system, methods
tailored to the model system, and the inclusion of three SFGR, Rickettsia rickettsii, R. parkeri, and R. am-
blyommatis, that overlap in geographic distribution but range in their ability to cause human disease. The most
virulent SFGR in our system is Rickettsia rickettsii, the agent of Rocky Mountain spotted fever (RMSF), a
potentially fatal SFR. Rickettsia parkeri was confirmed as an agent of SFR approximately 20 years ago and
causes a milder SFR than RMSF. The third SFGR in our proposed studies is R. amblyommatis, which is not a
known SFR agent but may be associated with mild symptoms and confound SFR diagnosis. While all three
SFGR overlap in their eastern US range, R. parkeri, in its Amblyomma maculatum tick vector, and R. am-
blyommatis, in its A. americanum tick vector, are more commonly encountered compared to R. rickettsii in its
Dermacentor variabilis tick vector. The long-term goal of our research is to elucidate the immune response to
SFGR and determine the mechanisms that lead to the development of SFR using a relevant experimental
system. Our objectives for this R01 resubmission are to differentiate immune effector profiles in the skin after
tick transmission of SFGR associated and not associated with SFR and to identify acute disease biomarkers.
We address the hypotheses that unique local immune profiles are generated from guinea pigs exposed to tick-
transmitted SFGR that differ in virulence. These unique profiles may reveal potential mechanisms driving the
immune response to SFGR under natural conditions. Further, biomarkers identified during acute infection will
inform SFR progression and clearance. Our rationale is that immune effectors and biomarkers in a relevant
model system will best clarify SFR and provide reliable approaches to treatment and diagnostics. The pro-
posed research is significant because it will position the guinea pig-tick-SFGR system to address more pro-
found mechanistic questions and thus better inform future development of therapeutics and diagnostics com-
pared to the use of the murine model. This proposal is innovative by combining expertise in the uniquely
translational guinea pig-tick-SFGR system and immunology, including assay development, with studies of SFR
agents and potential confounders of SFR diagnosis in the US.

Public health relevance
PROJECT NARRATIVE Our proposed research is relevant to public health because understanding the immune response to tick- transmitted rickettsiae and early markers for disease allows us to better predict disease prognosis. A short- term benefit is that continuing to refine our model system to better approximate human disease will provide more reliable data for public health decision-making. The long-term benefit of our research lies in its relevance to the NIH mission related to developing fundamental knowledge to reduce disease transmission and thus enhance health and reduce illness.